Arrestin proteins mediate microbial cellular adaptation and fungal virulence

Abstract
In order to effectively cause disease, microorganisms must continuously sense and respond to rapidly
changing environments. For microbial pathogens, these adaptive cellular processes include the ability to respond
to host-derived stresses. The robustness with which microorganisms regulate these adaptive responses largely
determines their ability to survive within the infected host.
In the experiments outlined in this proposal, we build upon recent and converging data from our laboratory
supporting the importance of protein ubiquitination in microbial host responses. Originally defined for directing
proteins for degradation, ubiquitination is increasingly recognized as a means of precise regulation of the
localization and function of many target proteins. In the human fungal pathogen Cryptococcus neoformans, we
have identified the Rsp5 ubiquitin ligase as a key mediator of stress response and virulence. Our preliminary
experiments have begun to define the specific aspects of the pathogenic process that require Rsp5 activity,
including cell wall homeostasis and cell cycle progression. Consistent with emerging models of ubiquitination in
diverse species, our experimental results suggest that Rsp5 is directed to its protein targets by adaptor proteins,
including the arrestin protein family. Our initial in vitro and in vivo experiments indicate that the virulence-
associated phenotypes of the C. neoformans rsp5 mutant are likely a composite of individual contribution of
altered target protein function. By further defining the microbial ubiquitin ligase / adaptor / target protein axis, we
will more deeply explore the mechanisms by which stress-induced cellular responses influence fungal infections.

Public health relevance
Project Narrative We will explore new mechanisms by which infectious microorganisms respond to cell stresses, especially those encountered in the infected host. Using the opportunistic human fungal pathogen Cryptococcus neoformans as a model, we have demonstrated the importance of ubiquitination as a chemical modification of microbial stress-related proteins to control their stability and function. Given the importance of stress-response in the microbe-host interaction, these processes are required for the establishment and maintenance of infections.